The Effects of the SCN1B Mimetic Peptide Badp1 on the Regulated Intramembrane Proteolysis Pathway

Project Summary
Sudden cardiac death (SCD) caused by arrhythmia continues to be prevalent in the US and the world. Many
drugs that aim to correct or prevent arrhythmias target ion channels, including the voltage-gated sodium
channel (VGSC). The perinexus is a specialized nanodomain of the intercalated disc directly adjacent to gap
junctions. It has been shown by our group that the VGSC subunit SCN1B/β1 is critical to perinexal adhesion.
Loss of adhesion and widening of the perinexus leads to slowed conduction velocity and increased incidence
of arrhythmia. As yet, no drug targeting β1 has yet been explored in preventing arrhythmias. My preliminary
data indicates that >24 hour treatment with βadp1, a mimetic of the β1 extracellular domain, may result in
upregulation of the VGSC β1 subunit, as well as increased levels of intercellular adhesion in β1-expressing
1610 cells, as measured by electric cell-substrate impedance sensing (ECIS). The proposed research aims to
test the overarching hypothesis that targeting the adhesion function of the VGSC β1 subunit with βadp1 will
result in increased abundance of β1 in the plasma membrane, increased β1-mediated adhesion, and a
narrower perinexus over 24-48 hours of treatment. Furthermore, I will test the mechanistic hypothesis that
βadp1 upregulates intramembrane proteolysis (RIP) of the β1 subunit, which was recently reported to alter
gene transcription of many important electrogenic proteins, including VGSC subunits. In specific aim 1, an
established cell line stably expressing the VGSC β1 subunit (Chinese hamster lung fibroblast 1610 cells) and
isolated neonatal rat cardiomyocytes will be used to assay effects of βadp1 treatment in vitro over 48 hour
time-courses in the presence and absence of inhibitors of RIP. Assessments will include ECIS assays of
intercellular adhesion, and monitoring of protein and gene expression responses by Western blotting,
quantitative IF, RNA-Seq and qPCR. In specific aim 2, effects of βadp1 treatment over 48 hours in vivo will be
tested in guinea pigs, including studies of cardiac conduction using optical mapping, perinexal ultrastructure
using transmission electron microscopy and monitoring of protein and gene expression responses using similar
approaches to aim 1. The goal of my research is to gain further insight into βadp1 mode-of-action and its
effects on heart structure and electrophysiological function, as well as to use this knowledge as a path to
develop therapeutics for preventing fatal arrhythmias. In addition to completing the research aims, the purpose
of this fellowship is to enable me to gain training in new techniques and areas of research, to undertake
professional development, and also develop skills in mentoring and communicating science. The research will
be performed under the guidance and expertise of Dr. Rob Gourdie. Training in optical mapping of electrical
activation will be done with Dr. Steve Poelzing, training in RNA-Seq analyses will be under the expertise of Dr.
Yassine Sassi, and training in ECIS will be done with Dr. Charles Keese.

Public health relevance
Project Narrative Sudden cardiac death caused by arrhythmia is prevalent in the world. Although many drugs aim to prevent arrhythmias by targeting ion channels in the heart, one target that has not been explored is the β1 subunit of voltage gated sodium channels. The aim of this research is to develop, test, and describe the molecular mechanism through which a mimetic peptide drug targeting the β1 subunit of voltage gated sodium channels may be highly successful in treating such arrhythmias.